Observational fear enhanced plasticity in dmPFC-BLA circuit as a modulator of affective behaviors

Project summary
Forming stronger aversive memories is a characteristic of PTSD. Meanwhile, psychological
trauma is a risk factor for developing PTSD in the future, upon exposure to another adverse
event. This project will use mice to investigate how observing fear in others, as a form of social
distress, enhances the retention of new inhibitory avoidance (IA) memories. It serves our long-
term goal to understand how neuronal plasticity contributes to emotional behaviors and to
identify the means for reversing PTSD-relevant behavioral traits by artificial circuit
manipulations. We have recently found that a brief exposure to a conspecific receiving electrical
footshocks, the observational fear paradigm (OF), enables a stronger inhibitory avoidance (IA)
learning in mice.
Our preliminary data strongly implicate the pathways between the dorsomedial prefrontal cortex
(dmPFC) and basolateral amygdala (BLA) pathway in the enhancement. First, a
pharmacogenetic disconnection of these structures during OF prevented the enhancement.
Second, OF enabled facilitation of this pathway by IA training, which lasted for several hours.
Third, OF generated NMDAR-only (silent) synapses, which we unsilenced by IA training. In
addition, OF attenuated GABAbR-mediated depression of the feedforward GABAergic currents,
evoked in BLA neurons by a 5 Hz repeated stimulation of the dmPFC inputs. We will test a
hypothesis that OF enhances IA by generating silent synapses and by altering the GABAbR-
dependent inhibitory balance between PV- and Sst-IN in the prefrontal-amygdala circuit, both of
which enable a stronger synaptic facilitation during IA training. We will determine the necessity
of dmPFC-BLA synapses at each phase of the OF-IA paradigm (Aim 1), test the causal role of
the silent synapses and the transient synaptic facilitation (Aim 2), and identify the micro-circuit
mechanism responsible for the abnormally high plasticity (Aim 3). The study may inform about
potential targets and methods for early intervention to prevent PTSD in traumatized people.

Public health relevance
Project narrative Abnormal interaction between the amygdala and prefrontal cortex are implicated in mental disease, including disorders caused by social trauma, but underlying synaptic process has not been identified. Using a preclinical model, this study will test a hypothesis that observing fear in others alters synapses between the two structures to enable formation of stronger aversive memories in the future. The resulting basic knowledge may identify potential targets for preventing mental disease in traumatized people.